Core 3-Biostatistics

Core 3: Project Summary/Abstract
The Biostatistics and Bioinformatics Core 3 provides comprehensive service to guide design of
experiments, to optimize quantitative data analysis, and to maintain statistical justification and interpretation of
results. Specifically, Core 3 will implement sound experimental design principles that are tailored to address
specific scientific questions for each project. Core 3 will also carry out data analyses using suitable statistical
methods and bioinformatics algorithms, and will contribute to the interpretation of results through written
reports and frequent interactions with project investigators. Whenever appropriate, Core 3 will develop new
analysis tools to address new challenges in the analysis of various data, especially high-throughput genomic
and proteomic data. Members of Core 3 will participate in monthly SPORE meetings with all project
investigators, ensuring that statistical and data analysis/management issues are carefully considered during
all phases of each SPORE experiment. Thus, from inception to reporting and publication, basic laboratory
and translational experiments will benefit from the SPORE program that will be used to augment existing MD
Anderson Cancer Center biostatistics resources.

Public health relevance
Core 3: Project Narrative The Biostatistics and Bioinformatics Core (Core 3) of the Melanoma SPORE will play an integral role in the design of clinical trials, including data management, and active collaborative research. It will also provide comprehensive management of the quantitative aspects of all three projects as well as developmental research projects and career enhancement projects as and when awarded.